Emerging Products Core

SUMMARY/ABSTRACT
Drawing on concepts of `emerging infectious disease', the Emerging Products Core (EPC) will provide timely
data to Project Leaders about products whose profile (marketing, social media buzz) or use has increased in
the recent past (12 months) and/or is likely to increase in the near future (12 months). Emerging products may
be completely novel (i.e., a new form of nicotine delivery), a refinement of an existing product (e.g., a new
cigarette variety; a redesign of vaping or heated tobacco product), or a product introduced into a new market
(e.g., a Japanese HTP introduced in the US). The underlying goal of the Core is to centralize the production of
data related to product sale, characteristics, features, and chemical composition that can then feed the projects
within the P01, helping to improve research efficiency. This Core has two Specific Aims: Aim 1 is identify
emerging tobacco and nicotine products. Using multiple modes and data sources (INPAM surveys, web
scraping, social media rapid scans (e.g., Twitter), marketing reports (Nielsen and tobacco companies), stock
analyst reports, Securities and Exchange Commission (SEC) filings, patents submitted by and granted to
tobacco companies), we will identify and track emerging products, changes in sale/availability/prices of
products, and changes in products (e.g., new versions) in each country. We will focus on those emerging
products where evidence already exists of uptake, or products that have a strong likelihood of uptake among
youth and/or long-term smokers based on social media `buzz,' test marketing, advertising, and changes in
marketing or availability due to regulatory action. Aim 2 is to characterize design, labelling, contents, and
emissions of emerging products by category and country. Our focus will be on emergent products identified in
Aim 1 to determine, through physical and chemical analyses of the product, whether product design, chemical
ingredients, emissions, and/or performance differs and potentially is calibrated to specific regulations and
hence differ across jurisdictions with different policies. Results generated by the EPC can help to develop
survey items (Projects 1 and 2) to better adopt to the dynamically changing marketplace and provide context to
experimental or modeling studies (Projects 3 and 4). The EPC will make sure that information about products
is current and data is consistent across projects. We also expect that this data will be useful to WHO, FDA, and
other national and state regulators. Finally, we expect that data generated by EPC will be useful to researchers
outside of the P01 who can use this information to consider the impact of regulatory activities on product
popularity and its characteristics.

Public health relevance
NARRATIVE The Emerging Products Core (EPC) will provide timely data to Project Leaders about the state of the tobacco product market. Using multiple data sources, the EPC will identify and track emerging products in each country. It will then use physical and chemical analyses of those products to examine differences relevant to regulations.